Quorum sensing evolution and function in mixed bacterial communities

PROJECT SUMMARY
Bacteria – both beneficial and harmful – are primarily found in complex communities where they engage in
intricate social interactions with profound implications for human health. The focus of our work is on a type of
bacterial interaction involving cell-cell communication called quorum sensing, which is used by many bacteria
to coordinate group activities. Quorum sensing regulates virulence in many common pathogens and is used as
a model to explore general features of bacterial communication and cooperation in a broader sense. Prior
studies of quorum sensing have provided a mechanistic basis for understanding how these systems function in
monocultures; however, there remains a major gap in understanding the role of quorum sensing in mixed
microbial communities and dynamically changing populations. Such information will inform efforts to
manipulate quorum sensing as an anti-infective strategy and is fundamental to quorum sensing biology. The PI
has developed laboratory `synthetic ecological' models to study quorum sensing in mixed populations. These
models have enabled rigorous molecular- and population-level studies of the behavior and evolution of quorum
sensing. Results of our studies over the past five years have highlighted the crucial role of quorum sensing in
mixed-strain and mixed-species environments and demonstrated that quorum sensing functions differently in
different strains. These studies also showed that quorum sensing enables “eavesdropping” on the quorum
sensing signals of other bacteria. The overarching goal of this MIRA program is to combine our laboratory
models with molecular genetic and genomic approaches to expand our understanding of quorum sensing in
complex environments; from studies within individual strains with different genetic backgrounds to studies of
interactions between different strains and between different species. The proposed studies focus on three
future goals, which are to: 1) define how genetic adaptations alter quorum sensing regulation of antibiotic
resistance; 2) determine how different quorum sensing architectures influence cooperative interactions
between different strains; and 3) understand how bacteria use quorum sensing to eavesdrop on competitors.
Results of the proposed experiments will advance knowledge of quorum sensing and how bacteria behave in
complex communities, and ultimately inform efforts to target quorum sensing as an anti-virulence strategy.

Public health relevance
PROJECT NARRATIVE Bacteria use quorum sensing, a type of cell-cell communication, to coordinate behaviors that are important for the success of individuals and populations in complex environments, such as infections. We seek to understand the role of quorum sensing in mixed microbial communities and how quorum-sensing systems change in changing environments. These studies are fundamental to understanding bacterial community behavior and will inform efforts to manipulate quorum sensing to control infections.